CLINICAL TRIAL OF RASAGILINE MESYLATE IN EARLY PARKINSONS DISEASE

The primary objective of this study is to assess the safety and efficacy of rasagiline mesylate in patients with Parkinson's disease who are not receiving levodopa therapy.